Ultra-stable, photon-efficient cryogenic super-resolution fluorescence imaging for visualizing vitrified biological samples with molecular-scale resolution

ABSTRACT
Cryogenic electron microscopy (CryoEM) and cryo-electron tomography (CryoET) are powerful
techniques for visualizing macromolecular assemblies at a near-native state and in their
functional context inside cells; however the undiscriminating/non-specific contrast of such
techniques often complicates identifying regions of interest and specific molecular targets in
high-resolution cryoEM/cryoET datasets. Super-resolution (SR) fluorescence methods have
exquisite molecular specificity, but SR techniques have only achieved limited spatial resolutions
(~20-60 nm FWHM) when imaging vitrified biological samples at cryogenic temperatures. The
proposed project will create new ultra-stable, photon efficient cryogenic SR methods for imaging
vitrified biological specimens with true molecular-scale resolution (<2-3 nm FWHM), closing the
gap towards the (sub-)nanometer resolution of cryoEM/cryoET. The increased spatial resolution
will be leveraged for further development of powerful correlative light-electron microscopy
(CLEM) approaches that will ultimately enable elucidating the structural basis for many critical
macromolecular processes inside cells.

Public health relevance
Cryogenic electron microscopy (CryoEM) and electron tomography (CryoET) can visualize macromolecules in their native state inside cells, however the undiscriminating contrast of such techniques complicates identifying regions of interest and specific molecular targets in high-resolution cryoEM/cryoET data. Super-resolution (SR) fluorescence methods have exquisite molecular specificity, but SR techniques that image vitrified biological samples at cryogenic temperatures have only achieved limited spatial resolutions (~20-60 nm). The proposed project will create new ultra-stable, photon efficient cryogenic SR methods for imaging vitrified biological specimens with true molecular-scale resolution (<2-3 nm FWHM), closing the gap towards the (sub)nanometer resolution of cryoEM/cryoET and paving the way for powerful correlative light-electron microscopy, with transformative potential of elucidating the organization of macromolecular assemblies in cells.